Multilevel Longitudinal Models and Causal Networks for Childhood Obesity

DESCRIPTION (provided by applicant): The prevalence of obesity among US children and adolescents more than doubled between 1980 and 2004. Obesity frustrates health care providers because of its difficulty to reverse. Identifying children at high risk of obesity has been problematic, and it is difficult to identify causative factors at any level that are amenable to preventive interventions. We propose to develop and apply innovative statistical methods to the Fels Longitudinal Study (FLS) database to analyze multivariate and multilevel determinants of the increase in prevalence of childhood obesity over the past three decades. Repeated measurements of body size and composition from birth and frequent administration of questionnaires on lifestyle, diet, exercise and SES on the same individuals in the FLS over decades permits inferences of causality that cannot be supplied by cross-sectional data. We plan to use the multilevel longitudinal hierarchical models and Granger causality s that should be most susceptible to interventions to prevent or delay the onset of obesity in childhood. We will use serial data collected in 2076 individuals in the FLS, beginning in 1929, to develop multivariate and multilevel models and Granger networks to infer causality. We will validate these models and networks for their robustness by bootstrap methods and cross-validation and by using simulated data that mimics the FLS database. Our multilevel modeling and Granger causality networks of factors involved in the obesity epidemic should delineate plausible pathways and interactions among factors that explain and track the epidemic. Discovery and validation of these pathways and interactions should reveal optimal targets for simultaneous multilevel interventions to prevent obesity in childhood and/or to alter the time course of relevant causal variables. We assume that such multilevel interventions will be more successful than currently applied single level interventions in reducsocial, economic, dietary and other environmental variables. The study also permits discovery and analysis of cohort effects of social-environmental changes from 1929 through 2008. While investigations will be performed on risk factors for obesity, these methods will be applicable to other sets of variables. Our new methods should assist other investigators in planning longitudinal studies and in analyzing longitudinal data.

Public health relevance
PROJECT NARRATIVE The prevalence of obesity among US childrenand adolescents more than doubled between 1980 and 2004 and now stands at 16%. Once established, obesity is difficult to reverse. However, identifying children at high risk of obesity has been problematical, and it has been difficult to identify causative factors at any level that are amenable to preventive interventions. We propose to develop and apply innovative statistical methods to the Fels Longitudinal Study (FLS) database to analyze multivariate and multilevel determinants of the increase in prevalence of childhood obesity over the past three decades.